Recruitment for the efficacy trial of Tele-Harm Reduction in a federally qualified health center operated syringe services program

PROJECT ABSTRACT
This application is being submitted in response to PA-20-272 as an administrative supplement to DP2DA053720-
01 (PI: Tookes). The T-SHARP (Telehealth Solution to HIV and Addiction-Related Problems) trial studies the
efficacy of the Tele-Harm Reduction intervention in 3 syringe services programs (SSPs) in Ending the HIV
Epidemic jurisdictions, Miami-Dade, Broward and Hillsborough counties. The aim of this administrative
supplement is to continue the T-SHARP trial of the Tele-Harm Reduction intervention at a Federally Qualified
Health Center based SSP, the SPOT. This expansion of trial sites will ensure the study meets enrollment targets
and that the intervention is feasible in varying SSP environments.

Public health relevance
PROJECT NARRATIVE Tele-Harm Reduction seeks to engage people who inject drugs (PWID) into HIV care by bringing healthcare out of the traditional healthcare system and leveraging syringe services programs as trusted venues to deliver telehealth-enhanced access to antiretrovirals, medications for opioid use disorder, and hepatitis C cure. We urgently need a robust evidence base to prove that Tele-Harm Reduction can help us End the HIV Epidemic in PWID and save lives. We seek to set the foundation to build a new standard of care to treat HIV among PWID.